Advanced Small Animal Ultrasound Imaging - Vevo F2

PROJECT SUMMARY/ABSTRACT
This proposal requests funds for the acquisition of a state-of-the-art Vevo F2 high-resolution ultrasound imaging
system (FujiFilm-VisualSonics). This system would be integrated into and managed by the Pre-Clinical
Cardiovascular (PCC) Core facility within the Division of Cardiology/Department of Medicine at the University of
Colorado Denver Anschutz Medical Campus (AMC). Due to the highly advanced technology of the Vevo F2,
this system would significantly expand the current capabilities of the PCC Core and would enhance on-going,
system-wide collaborations at the University of Colorado. The long-term objective of this proposal is to provide
advanced ultrasound capabilities that lead to a more detailed understanding of pathophysiological mechanisms
and highlight potential therapeutic strategies that could be translated into innovative treatments for human
diseases. Our goal is to do the best science possible and be guided by the data. Having a Vevo F2 instrument
in our PCC Core would undoubtedly help us achieve this goal.
A major focus of the PCC Core to facilitate studies employing mouse and rat models of cardiovascular,
pulmonary, renal, metabolic and onocologic diseases. Our ultimate goal is to translate findings made in these
pre-clinical models into novel therapeutics for the treatment of devastating diseases in humans. We collaborate
closely with research groups across the campus, and the entire Denver metropolitan area, to understand the
roles of heart:kidney and heart:lung cross-talk in the pathogenesis of cardiorenal disease and pulmonary
vascular/right ventricular remodeling. Additionally, we have collaborations focused on vascular stiffening,
impaired blood flow, metabolic disease, tumor metastasis, biomarker discovery and contrast imaging in rodent
models (see Figure). All of these efforts would benefit from the acquisition of a Vevo F2 instrument, which would
enable state-of-the-art, non-invasive, longitudinal measurements of cardiac structure and function, renal, cardiac
and pancreatic blood flow, and tumor formation in mouse and rat models. In addition, this high-definition
ultrasound system would provide an invaluable tool for monitoring localized delivery of cells and therapeutic
agents via intra-cardiac or portal vein injection. The
Vevo F2, which has many features in common with
clinical instruments, would have a tremendous impact
on NIH-funded research at the University of Colorado
Anschutz Medical Campus, and has the potential to
facilitate translation of basic science discoveries into
innovative treatments for human disease.
In addition to the aforementioned collaborations,
through fee-for-service arrangements, the PCC Core
serves a diverse group of investigators, not only on
the AMC, which has two separate animal facilities, but
also in the Colorado Children's Hospital, the Rocky
Mountain Regional VA Medical Center, and University
of Colorado Boulder. We are also deeply committed
to assisting early stage investigators obtain
preliminary data to support their first NIH grant
applications. For all of these studies we employ two
Vevo 2100 instruments, which are located in a
pathogen-free animal facility in Research Center 2
(RC2). The upgrade to the Vevo F2 is crucially
needed to meet the increasing demands, and
technical needs, of a multitude of projects, which have
tested the limits of the Vevo 2100 instruments that we
purchased in 2014. Not only is the technology of this
instrument inferior to that of the Vevo F2, but the Vevo
2100 will no longer be serviced by FujiFilm-VisualSonics starting in 2023. Furthermore, the Vevo 2100 uses a
Windows XP operating system, which is not compatible with the IT requirements of the University of Colorado.
It is essential that we obtain a Vevo F2 to maintain and promote cutting edge biomedical research at the
University of Colorado.

Public health relevance
PROJECT NARRATIVE In order to develop new treatments for diseases, it is important to study diseases ‘pre-clinically’ using animal models. We are requesting funds to purchase a state-of-the-art ultrasound imaging system that will enable us to study many diseases, including cardiovascular disease, lung disease, diabetes and cancer, in mice and rats. This system, the Vevo F2, would be the only such imaging instrument in the University of Colorado system, and would enhance NIH-funded research across the Denver metropolitan area.